Biostatistics & Bioinformatics Shared Resource

BIOSTATISTICS & BIOINFORMATICS SHARED RESOURCE: PROJECT SUMMARY
The goal of the Biostatistics & Bioinformatics Shared Resource (BBSR) is to provide basic, translational, clinical,
and population science Georgetown Lombardi Comprehensive Cancer Center (LCCC) Members with access to
high-quality statistical science and bioinformatics. BBSR provides education, training, and mentorship for
oncology fellows, tumor biology graduate students, and members through workshops, consulting clinics,
courses, and research study design and analysis. The BBSR was established and has been CCSG-funded since
2006 and is co-directed by Ming Tan, PhD, Chair of the Department of Biostatistics, Bioinformatics and
Biomathematics (DBBB), and Yuriy Gusev, PhD, Associate Professor of Bioinformatics, and Bioinformatics Lead
for Innovation Center of Biomedical Informatics (ICBI) at Georgetown University. The BBSR includes 12 highly
qualified and experienced biostatisticians and bioinformaticians. BBSR provides LCCC Members with access to:
(1) study design, statistical analysis and reporting of research studies, such as clinical trials, those with high-
dimensional omics and imaging data (including pathway analysis and computational modeling); (2) support for
electronic health record -based cohorts and research; (3) engagement in clinical research with membership on
Clinical Research Leadership Committee , the Protocol Review and Monitoring Committee and the Data and
Safety Monitoring Committee; and (4) biostatistics and informatics training and expertise in collecting, integrating,
managing, and applying biomedical data to transdisciplinary cancer research projects. In addition, the BBSR has
independently developed novel statistical and bioinformatics methods and tools that are available to all LCCC
Members. BBSR supports members in all three LCCC Research Programs (Cancer Cell Biology [CCB], Cancer
Prevention and Control [CPC], and Cancer Host Interactions [CHI]); as well as the Clinical Protocol Data
Management Office; and works collaboratively with multiple Shared Resources, including the Genomics &
Epigenomics Shared Resource, the Survey, Recruitment & Biospecimen Collection Shared Resource, and the
Mass Spectrometry & Analytical Pharmacology Shared Resource. Through these activities, BBSR provides
multidisciplinary statistical science and bioinformatics training and serves to support LCCC cancer research
efficiently and effectively. The BBSR supports the development and maintenance of standardized and scalable
information architecture to connect data and metadata from clinical, biospecimen and research systems to
enable cancer research. In FY2022, the BBSR provided services to 44 LCCC Members across all three Research
Programs (12 CCB Members, 13 CHI Members, and 19 CPC members. In FY2022, 55% of BBSR’s total usage
was from LCCC Members. In the current project period, the BBSR contributed to 82 publications, including 14
publications in high-impact journals, and provided support that enabled the success of 50 extramurally funded
research project grants, and 55 investigator-initiated trials led by LCCC Members.